Global Network for Women's and Children's Health Research Data Coordinating Center

Project Summary/Abstract
To improve women’s and children’s health and make progress in addressing the U.N.’s Sustainable
Development Goals (SDGs), there is a need to continue researching sustainable, cost-effective health
interventions and strengthening research infrastructure and public health intervention capabilities in
developing countries. The NICHD Global Network (GN) is critical to helping the U.S. government address the
SDGs to reduce maternal mortality and end preventable newborn and child mortality. There is a crucial need
for an independent Data Coordinating Center (DCC) to provide statistical and operational expertise that
helps the GN complete high-impact research to influence policy. RTI has been the GN’s DCC since 2001
and proposes to continue in this role for the next cycle. We will maximize the global impact of the GN and
ensure a productive and accessible GN by collaborating with study investigators—both within and outside
the Network—to develop rigorous and relevant Network research protocols and budgets. We will ensure
seamless incorporation of research protocols developed by both GN and non-Network investigators through
systems developed to inform study design using knowledge of the GN sites. (1) Optimize the scientific
quality and operational efficiency of GN studies by supporting protocol design, training, implementation, and
study monitoring; developing rigorous statistical analysis plans; incorporating common data elements; and
effectively procuring external services, as needed, to support the research implementation. (2) Ensure high-
quality data collection and data management, rigorous monitoring of study progress, quality, and participant
safety. (3) Maximize the validity and scientific impact of Network research by providing timely, accurate
statistical analyses of GN research to support publication of study results; ensuring timely dissemination and
public sharing of data at study completion; and supporting study oversight by the Data Safety Monitoring
Board, the Steering Committee, research units, NICHD. (4) Enhance the efficiency, productivity, and
outreach of Network operations to Network and non-Network investigators by providing broad logistical
support, including telecommunications, meeting coordination and organization, web-based internal and
external communication systems, and regulatory support. Dr. Elizabeth McClure, the proposed PI, has
extensive experience in maternal and newborn studies, and will be assisted by senior research staff with
significant GN experience. This application has unique strengths to help advance the GN research agenda:
(1) a highly qualified, collaborative PI and staff with in-depth knowledge; (2) proven track record of scientific
productivity and leveraging the GN infrastructure to address emerging issues to advance NICHD scientific
goals; (3) robust data systems customized for the GN to ensure data quality for harmonized research; (4)
experts in biostatistics, epidemiology, community health, nutrition, infant development, and health
economics; and (5) a flexible administrative structure to help realize the NICHD vision to optimize the GN.

Public health relevance
Project Narrative NICHD established the Global Network for Women’s and Children’s Health Research to improve health outcomes for women and children in low- and lower middle-income countries (LMICs) by researching sustainable, cost-effective health interventions and strengthening research infrastructure and public health intervention capabilities in LMICs. A Data Coordinating Center (DCC) provides essential expertise for a large multi-country research network by ensuring rigorous, harmonized standards for study design, development, data collection, and data analyses and high-quality implementation across a range of diverse settings. The DCC also coordinates communications, supports the regulatory approval process, procures study equipment and supplies and provides logistical support across diverse research sites, both inside and outside the Global Network.